Administrative

The purpose of the Administrative Core (Core A) is to provide administrative support to the Program Director, to the Project Leaders of the individual projects, and to the scientific personnel of the Projects and Cores. Core A will provide a key administrative and organizational role that will enable the Project Leaders, their staff and the scientific cores to focus on their experimental and scientific efforts. The specific tasks of Core A will be to: a) facilitate interactions between Program investigators. Scientific Advisors/Consultants and administrative personnel; b) to plan and coordinate the meetings between the Project Leaders and their staff; c) to plan and coordinate the internal scientific advisory committee interactions with the Project Leaders and their staff; d) to plan and coordinate travel for the external scientific advisory committee members, the Project Leaders and their professional staff; e) to assist in assembling and maintaining the timely submission of multi-user and individual lACUC protocols that cover the efforts included within this program; f) to facilitate resource sharing between the Project Leaders; and g) to assist the Project Leaders in preparation of progress reports, financial reports and manuscripts for publication.